Rodent Behavior Core

The UC Davis MIND Institute IDDRC Rodent Behavior Core (RBC) is fundamental to Center projects seeking to understand the biological mechanisms underlying IDD and to pursue translational discovery of therapeutics. This is a completely new core that builds on existing and newly available resources and expertise at the MIND Institute and UC Davis. Its goal is to meet the high demand for behavioral testing of rodent models of IDD at UC Davis. The RBC will assist investigators with IDDRC projects in generating high-quality behavioral data for publication, preclinical discoveries to inform human clinical trials, and pilot data for new studies. Further, the availability of the services of the RBC is likely to encourage additional UC Davis researchers to become interested in entering the IDD research field and becoming members of the IDDRC, and we will support this interest through active outreach efforts. Comprehensive behavioral assays relevant to IDD, including those developed by Drs. Crawley and Berman, are employed worldwide to understand causal mechanisms and develop effective therapeutics. The proposed RBC will employ standardized and innovative behavioral assays relevant to the behavioral symptoms of IDD. Services will include (a) access to modern, efficient, start-of-the-art behavioral testing facilities; (b) training for investigators and their staff in behavioral assay procedures and the use of behavioral testing equipment; (c) hands-on supervision in all aspects of behavioral testing and equipment use; (d) consultation on experimental design and interpretation of results; (e) assistance in developing new assays required by users; (f) training and supervision in drug administration for behavioral pharmacology studies; (g) access to facilities for harvesting tissue from behaviorally tested mice and rats; (h) access to mutant mouse and rat models; (i) guidance to access related resources at UC Davis, including core facilities for genetics and for generating new lines of mutant mice; and (j) facilitation of collaborations between IDDRC investigators. Services will further include (k) consultation for preparing lACUC protocols, grant applications, and manuscripts. In addition, the core will offer (I) direct behavioral testing services conducted by core staff. Expertise of the core director, co-director, and managers includes extensive knowledge and experience in animal models of IDD conditions, behavioral phenotyping of mice with targeted gene mutations, behavioral phenotyping of inbred strains of mice and rats, and behavioral responses to drug treatments, immune challenges, and environmental toxins in mice and rats. Mouse facilities are located at the UC Davis School of Medicine campus in Sacramento. Rat facilities are located at the nearby main campus in Davis. A high level of scientific and practical interactions is already in place between the two sites. Five tiers of service usage will be offered: (1) consultation; (2) unsupervised use of equipment available in the core facilities; (3) training and supervision in conducting behavioral tests using core equipment; (4) battery of assays conducted by core staff; and (5) tailored sets of assays conducted by core staff. Combinations of services will be designed to match the needs of each user.